Core C: Data Management and Statistics Core

DATA MANAGEMENT AND STATISTICS CORE - CORE C: PROJECT SUMMARY/ABSTRACT
The Data Management and Statistics Core (Core C) of the Johns Hopkins Alzheimer’s Disease Research
Center (JHADRC) has five overarching goals: (1) to provide database design, data management and data
distribution for investigators associated with the ADRC, both within the institution and at other ADC sites, (2)
to provide required data to the National Alzheimer’s Coordinating Center (NACC), (3) to provide statistical
expertise to investigators associated with the ADRC, including consultation to the Developmental Projects
funded by the JHADRC and to projects of the trainees supported by the Research Education Component
(REC), (4) to develop novel analytic methods for the study of ADRD, and (5) to mentor young investigators in
the field. Through the provision of efficient database design and data management, Core C assures the
accuracy, accessibility, and integration of data from the JHADRC. Efforts in the current cycle have
modernized our database; further high-end functionality will be added in the next cycle. Through the provision
of high level statistical consultation to investigators associated with the Center, a range of projects related to
the JHADRC will be supported. In this cycle we add expertise in machine learning and electronic health
records data to our highly experienced statistical team, and we partner to assure access to expertise in
imaging and ‘omics. Through the development of novel methods for the study of ADRD, additional insights
will be gained—with emphasis on methods to better evaluate cognitive decline, determine biomarker
trajectories leading to ADRD onset, and enable personalized, dynamic ADRD risk prediction. Through
mentoring young investigators, the next generation will be trained in statistical methods related to cognitive
decline and dementia.